Exosome treatment-induced mechanisms in chronic wound beds - Resubmission - 1

PROJECT SUMMARY
Chronic wounds present a costly social and medical dilemma, particularly in patients with type II diabetes, but
there are no effective treatments. These wounds are characterized by chronic inflammation, severe
microvascular complications, and therefore lack expansion of the granulation tissue and proliferation necessary
to heal the wound. Recently, exosome administration has emerged as a potent therapy for promoting wound
healing but the mechanisms underlying the therapeutic effect are mostly unknown. Exosomes are secreted
membranous nanovesicles that can be isolated from cell culture of multipotent stromal cells. In a preclinical type
II diabetic model, a single local administration of exosomes was very effective and reduced time to closure to
nearly that of wild type mice. We found extensive neovascularization in granulation tissue of exosome-treated
wounds and presence of large numbers of macrophages immunoreactive for arginase1, typically indicative of a
pro-healing phenotype. Exosomes from multipotent stromal cells carry plasminogen activator inhibitor-1 (PAI-1)
among other angiogenesis-associated proteins. When we applied a PAI-1 inhibitor simultaneously with
exosomes, the beneficial effect of exosome treatment was partially mitigated. Exosomes can have multiple
signaling pathway targets, and PAI-1 is a major component. Our long term objective is to understand the
molecular mechanisms we need to address to alter the chronic wound state, and actually promote wound
closure. An approach like this is necessary to understand the rationale and safety of exosome treatment.
In this study, we are investigating the hypothesis that PAI-1 in bone marrow MPSC exosomes mediates
adaptive effects on macrophages and ECs in chronic wound beds, thereby promoting expansion of granulation
tissue with effective changes in wound healing trajectory. In Aim 1, we will determine whether overexpression or
loss of PAI-1 in exosomes affects the typically delayed diabetic wound healing. We will assess spatiotemporal
distribution of macrophages and endothelial cells. In Aim 2, we will analyze the changes in wound bed
macrophages and endothelial cells at a single cell resolution, using an integrated epitope and transcriptomics
approach. Additionally, in in vitro culture with inflammatory conditions, we will determine molecular changes in
macrophages and microvascular endothelial cells, downstream of exosome uptake. The results will demonstrate
the mechanisms orchestrating the efficacy of exosome treatment in normalizing inflammation and promoting
diabetic wound closure. We will perform the study under the mentorship of Dr. Bruce Cronstein, Dr. Ann Marie
Schmidt, and Dr. Thorsten Kirsch, and gain expertise in modeling chronic diseases in preclinical study designs,
hyper-inflammatory disease states, macrophage assays, and exosome-mediated mechanisms and cellular
communication in a chronic cutaneous wound bed. The collaborative and scientific learning environment at NYU
will provide the optimal setting to gain expertise in rational design of evidence-based translational research. This
training period will provide the scientific and career development rubric for an independent career in research.

Public health relevance
PROJECT NARRATIVE Chronic skin wounds in patients with type II diabetes do not heal, as they are stalled at an inflammation phase without any growth of blood vessels that would typically close the gap. Exosomes, which are nanosized vesicles secreted by multipotent stromal cells and can be isolated from cell culture, show great promise in promoting faster closure in chronic wounds. In our study, we will investigate how exosomes and their cargo precisely affect major cell types in the wound, to resolve the stalled inflammation and let wound healing proceed.